Activated Protein C Signaling in Aging

Project Summary
Alzheimer’s disease (AD) is the most common form of dementia and is becoming a national health crisis as the
sixth leading cause of death in the United States. Prominent behavioral manifestations of AD include memory
loss and cognition with the pathological hallmark of the extracellular amyloid beta (A) plaques and intraneuronal
deposits of neurofibrillary tangles (NFTs) accumulation. Among that, A accumulation is proposed to initiate the
AD via damaging synapses and neurons. However, therapeutics targeting on Aβ hypothesis were found to have
little success. Therefore, identifying novel molecular and cellular factors underlying the pathogenesis of AD is
urgent in developing effective therapies. One of the important risk factors for AD is aging which is associated
with bioenergetic deficits, oxidized redox environment, and chronic inflammation that leads to synapse dysfunc-
tion and neuron damage. Our preliminary study showed that a novel age-related protein, activated protein C
(APC) plays a key role in the pathogenesis of AD via modulating the metabolic and redox homeostasis in the
brain. APC is a plasma protease exerting anticoagulant and cytoprotective effects, including modulating meta-
bolic pathways, repressing inflammation, and protecting neurons from stroke and trauma. Intriguingly, we found
that the depletion of APC in mice results in aging-like cardiac dysfunction and AD-like cognitive deficit symptoms.
Recombinant APC can block the deposition of amyloid plaque, improves cognitive behavior, and ameliorates the
cardiac dysfunction observed in AD model mice. Our long-term objective is to understand the roles and mecha-
nisms of APC in AD pathogenesis to develop an effective therapeutic strategy for the elderly with AD. At the
mechanistic level, APC depletion induces the derangement of metabolic and redox homeostasis in the brain
while APC treatment triggers activated protein kinase B (AKT) signaling which stimulates glucose metabolic rate,
represses cellular inflammatory signaling, and reduces amyloid plaques in AD. Therefore, we hypothesize that
APC plays a critical role in protecting neurofunction through maintaining metabolic homeostasis and repressing
neuroinflammatory responses against AD pathogenesis. This hypothesis will be tested by following two specific
aims: 1) To characterize the role of APC signaling in the pathogenesis of AD. 2) To elucidate the capability of
APC derivatives to improve neurofunction against AD. In addition, we will determine if the anticoagulant domain
of APC is important for its neuroprotective function to provide evidence that recombinant APC without anticoag-
ulant activity can be used for therapy of Alzheimer’s disease without the risk of bleeding.

Public health relevance
Project Narrative The project aims to investigate the mechanisms of a novel age-related endogenous protein, activated protein C (APC) in the pathogenesis of Alzheimer’s disease (AD). This study elucidates the capacity of recombinant APC derivatives in protecting neurofunctions in AD via regulating glucose metabolism and inflammatory responses. The findings could lead to novel therapeutic strategies aimed at preserving the neurofunctions from AD in the elderly.